IGF::CL::IGF: This Service is for Science Writer and Transcription charges for minute and meeting notes for the 2017 Biomarkers meeting

This Service is for Science Writer and Transcription charges for minute and meeting notes for the 2017 Biomarkers meeting